Task Order B-5_75N93022F00002; 09/19/2022-03/20/2023; $18,543.00.

To conduct research and development that would enhance the quality, functionality (e.g., sensitivity), and breadth of available tetramer reagents and decrease production time.